Investigating YAP1 control of differentiation and metabolism in Hepatoblastoma

Project Summary Hepatoblastoma (HB), the most common pediatric primary liver tumor, affects children from infancy to five years of age. Surgical resection with adjuvant chemotherapy has saved many young lives. However, the five-year survival rate remains at 70%, and is worse for children with unresectable tumors. Meeting the clinical need for HB-targeted therapies requires a better understanding of how HB tumors are formed and maintained. The transcriptional co-regulator YAP1 is hyper-activated in 79% of HB cases, and recent studies suggest that YAP1 and the Wnt/β-catenin pathway act together to initiate HB tumors. But is YAP1 required to maintain HB tumorigenesis? Preliminary studies using a conditional mouse model of HB—driven by doxycycline-inducible hyperactive YAP1S127A and constitutively-active β-catenin—suggest that YAP1 is essential for tumor maintenance. In the presence of doxycycline, YAP1 is expressed, and mice develop HB tumors; withdrawing doxycycline turns off YAP1, resulting in >90% tumor regression within 10 weeks. Transcriptional analyses revealed that hepatocyte differentiation factors and liver metabolic genes were induced in regressing tumors. The goal of this proposal is to understand how YAP1 dysregulates hepatocyte differentiation and reprograms hepatocyte metabolism. Using a conditional mouse model of HB, Aim 1 will investigate how YAP1 regulates critical hepatocyte differentiation factors—HNF4a and FoxA2—to maintain HB tumorigenesis. Genetic tests will be used to determine whether HNF4a and FoxA2 are necessary or sufficient to promote tumor regression and differentiation. Genomic and biochemical approaches will be used to assess binding and affinity of the YAP1- TEAD complex to HNF4a and FoxA2 genes. Results from Aim 1 will provide insight into how YAP1 affects differentiation status and may have important prognostic implications for HB patients. Aim 2 will investigate how YAP1 maintains tumorigenesis by reprogramming hepatocyte metabolism. The glycolytic enzyme activity of pyruvate kinase M2 (Pkm2) will be measured in YAP1-dependent tumors and during tumor regression in conditional HB mice. RNA interference will be used to determine whether Pkm2 is required for YAP1-dependent tumor maintenance. This aim will examine previously uncharacterized YAP1 and Pkm2 regulation of tumor metabolism. Findings from this study will provide insight into the mechanisms of YAP1 in HB tumorigenesis and may define new prognostic factors and druggable targets to treat children suffering from HB.

Public health relevance
Project Narrative Hepatoblastoma is the most common childhood liver cancer. This proposal introduces a new inducible model of hepatoblastoma and seeks to understand how tumors are maintained and how tumors regress. These studies could inform therapies to treat hepatoblastoma and other liver cancers.